Role of neuraminidase activity on endothelial dysfunction in type 2 diabetes

PROJECT SUMMARY/ABSTRACT
Endothelial dysfunction is causally implicated in the development of cardiovascular disease (CVD), the main
cause of death in patients with type 2 diabetes (T2D). The endothelium regulates arterial diameter and
vascular homeostasis via the production of a myriad of vasoactive substances including nitric oxide (NO). NO
is a powerful vasodilator produced in response to blood flow-induced shear stress, which is detected by
mechanosensitive endothelial luminal structures. The glycocalyx is such a mechanosensor. It consists of a
mesh of interwoven glycoproteins and proteoglycans that, when disturbed by shear stress, converts
mechanical forces into biochemical signals. The appropriate result of this process, known as
mechanotransduction, is endothelium-dependent flow-mediated dilation (FMD), which is considered the gold-
standard physiological measure of endothelial function. Notably, impaired FMD is highly prevalent in T2D and
also represents a critical component of the mechanisms that lead to CVD. However, despite the major role
that reduced FMD plays in T2D-associated CVD development, the mechanisms that lead to this abnormal
response are not completely known. In addition, there are currently no specific therapeutic means to alleviate
impaired FMD. A central goal of this proposal is to decipher the mechanisms underlying the impairment of
FMD in T2D and discover new therapeutic targets to improve it. Based on our prior work and most recent and
exciting preliminary data, we propose the novel hypothesis that increased plasma neuraminidase activity
degrades glycocalyx structures via activation of ADAM17 (a disintegrin and metalloproteinase-17) and
promotes endothelial dysfunction in T2D. We will test our innovative hypothesis with gain- and loss-of-function
pharmacological and genetic-manipulation experiments in human cultured endothelial cells and isolated
arteries, in animal models of neuraminidase ablation and T2D, and in patients with T2D. Specifically, in Aim 1,
using cultured endothelial cells and isolated arteries from humans, we will determine the mechanisms by which
neuraminidase activity increases endothelial ADAM17 activation and impairs FMD. Subsequently, in Aim 2,
we will determine the effects of neuraminidase inhibition on endothelial function in animal models and patients
with T2D. We hypothesize that neuraminidase inhibition in T2D mice or humans improves FMD and overall
vascular function. Our team is poised to move cardiovascular and diabetes research forward with a project
that will exert a sustained, powerful impact across a number of levels of inquiry that are novel conceptually,
mechanistically, methodologically, and therapeutically. Indeed, targeting neuraminidase activity holds
extraordinary promise for correcting endothelial dysfunction in T2D and ultimately preventing/treating T2D-
associated CVD.

Public health relevance
PROJECT NARRATIVE Endothelial dysfunction is a primary risk factor for the development of cardiovascular disease, the main cause of death in patients with type 2 diabetes. The proposed study will determine the role of neuraminidase activity in degrading glycocalyx structures and promoting endothelial dysfunction in type 2 diabetes.